Geo-enabled detect and respond system for antimalarial resistance in Ghana: GDRS - Ghana

Project summary
Antimalarial drug resistance is a continuing challenge in the global effort to control and eliminate malaria. Well designed,
rapid and highly granular antimalarial surveillance systems are urgently needed to protect the efficacy of remaining
antimalarial treatments and inform discovery of new, effective drugs and vaccines. Molecular markers are useful tools to
monitor anti-malarial drug resistance and, if used in routine surveillance, could help to detect and monitor the early
emergence of resistance before it translates to treatment failures.
This project will address the need for more powerful molecular surveillance through a strategic collaboration between
two geographically and scientifically complementary, Africa-based networks - the DS-I Africa INFORM Research Hub
and the West African Center for Cell Biology for Infectious Pathogens (WACCBIP). Akros and the Institute for Human
Virology Nigeria, both part of the INFORM Research hub, will collaborate with WACCBIP to strengthen Ghana’s malaria
genomic surveillance network to include capture of community-level, geo enabled dried blood spot (DBS) samples and
expand this network to include additional epidemiologic and genomic data streams across geographies in Africa. This
partnership will leverage WACCBIP’s existing genomic surveillance ‘hub-and-spoke’ lab network and integrate the network
with the work of the DS-I Africa INFORM Research hub.
The deliberate, strategic plan to integrate WACCBIP with partners within DS-I Africa will expand geographic coverage
of geospatial surveillance through pivoting the open-source ‘Reveal’ geospatial platform already in use by DS-I Africa.
With the use of Reveal, the consortium will geoenable WACCBIP’s existing malaria genomic surveillance network and
expand the platform to link DBS data collected at the household level to advanced next generation sequencing (NGS) labs.
Through this project, stakeholders will be equipped to visualize and monitor molecular markers of antimalarial resistance
captured from the DBS samples, and geospatially align these genomic data to other data streams including epidemiologic,
programmatic, and socio-demographic data to inform intervention response. The linking and geoenabling of the existing
surveillance network to the Reveal platform will increase granular geospatial and temporal antimalarial resistance
insights to guide responsive action and drive epidemiological understanding of antimalarial resistance emergence and
spread.
We envision this project will provide a model for a) geoenabled community-level genomic surveillance, b) better
understanding of the manifestation of antimalarial resistance at a granular level, and c) timely access to critical evidence
to guide national decision-making for malaria program response and adaptation.

Public health relevance
The knowledge generated through this work has direct relevance to U.S. public health, particularly in terms of integrated geospatial and genomic surveillance and response systems for arboviral disease, which are increasingly important for monitoring vector-borne diseases such as West Nile virus, Zika, chikungunya, dengue and Lyme disease. Findings from this study will inform the design, deployment, and sustainability of digital genomic surveillance platforms applicable to the U.S., thereby strengthening data-to-decision systems critical for emerging infectious diseases as well as pandemic preparedness response. By leveraging existing NIH-supported digital health infrastructure in West Africa, the project provides a scalable, replicable, and repeatable model for evaluating implementation of advanced surveillance technologies in real-world settings.